Microglia and S1PR1 Signaling in Multiple Sclerosis Associated Neuropathic Pain

Project Summary
Neuropathic pain afflicts well over half of people living with multiple sclerosis (MS). Current treatments for MS
were designed to delay motor symptom progression, but do not address MS associated neuropathic pain
(MSNP). This is due in part to a lack of understanding about the underlying mechanisms that drive MSNP. The
pathophysiology of MS includes proinflammatory microglial activation that is recapitulated in the experimental
autoimmune encephalomyelitis (EAE) mouse model of MS. Both pharmacological inhibition and genetic
knockout of microglia-specific proteins prevented the development of or suppressed established neuropathic
pain behaviors in non-MS models of neuropathic pain. These studies indicate that microglia activation mediates
the behavioral signs of MSNP. Fingolimod is an FDA approved MS drug that reduces allodynia and hyperalgesia
in several rodent models of chronic pain, including peripheral neuropathic pain; however, the site and mechanism
of antiallodynic action of fingolimod in central neuropathic pain, e.g., MSNP, remains unknown. Our laboratory
reported that repeated administration of intraperitoneal fingolimod attenuated neuropathic pain-like behaviors in
EAE, and these effects could be blocked by sphingosine-1-phosphate receptor 1 (S1PR1) antagonists or
mimicked S1PR1 agonists. Our results raised the idea that fingolimod acts as an agonist at S1PR1 to elicit
antiallodynic effects in EAE.
Fingolimod reduces microglial activation in MS and primary cell culture. Because Gi-GPCR activation in microglia
inhibits or blocks inflammation, and S1PR1 is a Gi-GPCR, I propose the overall hypothesis that fingolimod
leads to S1PR1 activation and subsequent microglial inhibition that explains its anti-allodynic effects in EAE.
Specific Aim 1 will test the hypothesis that spinal microglia-dependent mechanisms maintain MSNP. I will deplete
microglia in the whole CNS or spinal cord (Aim 1.1/1.2) and chemogenetically inhibit spinal microglia (Aim 1.3)
in EAE mice. I predict that each approach will attenuate EAE-induced allodynia. Specific Aim 2 will test the
hypothesis that the spinal S1PR1 agonist actions of fingolimod reverse MSNP behavior through inhibition of EAE
induced activation of pro-inflammatory microglia. Aim 2.1 predicts that intrathecal injection of fingolimod will
reduce EAE-induced allodynia, and that this can be blocked by pre-administration of S1PR1 antagonists. Aim
2.2 predicts fingolimod will stimulate spinal G-protein coupling (assessed with in situ [35S]GTPγS binding assays)
that is blocked with S1PR1 antagonists and increased in EAE, indicating an S1PR1 dependent mechanism that
allows fingolimod to exert greater analgesic actions in EAE compared to controls. Aim 2.3 predicts that knockout
of S1PR1 on microglia will prevent the antiallodynic effects of intrathecal fingolimod and S1PR1 agonists in EAE.
This would indicate that fingolimod mediates MSNP through a microglial S1PR1-dependent mechanism.

Public health relevance
Project Narrative Neuropathic pain in multiple sclerosis (MS) afflicts over 50% of patients; however, currently available analgesic drugs are inadequate, due in part to a lack of understanding about the underlying mechanisms that drive multiple sclerosis-associated neuropathic pain (MSNP). This proposal aims to use cellular manipulations and pharmacologic interventions to elucidate microglial mechanisms that will guide future development of non-opioid therapeutics to treat MSNP. We focus on the FDA-approved S1PR1 agonist, fingolimod, not only for its disease modifying properties, but also as a treatment for the pain of MS.